Using microsphere technology for the electrochemical measurement of genotoxicity.

Application Identiﬁer: 1813380 Using microsphere technology for the electrochemical measurement of genotoxicity.
Project Summary
The increasing integration of engineered nanomaterials (ENMs) in personal care products presents signiﬁcant
health and safety challenges. ENMs like titanium dioxide and zinc oxide nanoparticles are highly reactive and
capable of penetrating cells, posing unknown long-term risks to human health. Research has demonstrated that
these nanomaterials exacerbate DNA damage under ultraviolet (UV) radiation, leading to increased genotoxicity
and potentially contributing to cancer initiation. However, current toxicity evaluation methods lack the scalability
and precision to assess the combinational effects of ENMs, UV radiation, and chemical agents, leaving a critical
gap in public health safety testing.
The SphereDNA® platform addresses this gap by introducing a novel high-throughput (HTP) genotoxicity screening
approach. Leveraging microﬂuidic impedance cytometry, SphereDNA® measures DNA damage by detecting
changes in electrical impedance as DNA migrates within a 50 µm agarose microsphere. The microsphere
encapsulates mammalian cells, and upon lysis, the DNA is unwound in an alkaline environment. Damaged DNA
migrates further through the microsphere, proportionally reducing its impedance. This label-free technique
eliminates the need for ﬂuorescent imaging, signiﬁcantly increasing throughput and reproducibility while reducing
costs.
SphereDNA® is designed for modular scalability, enabling testing of thousands of samples in parallel, making it
uniquely suited for evaluating complex exposures under realistic conditions. The platform aligns with the NIEHS
Nano Environmental Health and Safety program's goals to detect, quantify, and assess the toxicological potential
of ENMs. By providing an innovative and cost-effective solution, SphereDNA® empowers researchers, industry, and
regulators to mitigate public health risks and improve oversight of ENM-containing products.

Public health relevance
Application Identifier: 1813380 Using microsphere technology for the electrochemical measurement of genotoxicity. Narrative: This project addresses the urgent need for improved testing of the combinational genotoxicity of skin products, including medications, sunscreens, and cosmetics. The proposed SphereDNA™ technology uses innovative microfluidic impedance cytometry to enable rapid, cost-effective, and high-throughput genotoxicity screening without the need for labeling. This platform will enhance product safety evaluations, protecting public health and ensuring regulatory compliance.